Mitochondria and calcium signaling in skeletal muscle

DESCRIPTION (provided by applicant): Ca2+ controls numerous cellular processes in skeletal muscle and alterations in Ca2+ homeostasis are associated with human diseases such as Duchenne Muscular Dystrophy (DMD), Malignant Hyperthermia (MH) and Central Core Disease (CCD). Defining the molecular mechanisms regulating intracellular Ca2+ signaling is a crucial step for developing new therapeutic interventions in these myopathies. The release of Ca2+ from sarcoplasmic reticulum (SR) via Ca2+ release channels (ryanodine receptors, RyRs) is a key step in skeletal muscle excitation-contraction coupling (ECC). It is triggered through a direct interaction of the plasmalemmal voltage sensors with RyRs and it is thought to be amplified by Ca2+-induced Ca2+ release (CICR), manifest as Ca2+ sparks. However, mature mammalian muscle does not display Ca2+ sparks during physiological ECC but it develops spontaneous spark activity under various pathophysiological conditions. The molecular events that lead to Ca2+ spark generation in mammalian muscle are unknown. Understanding these mechanisms is a prerequisite to prevent changes in Ca2+ homeostasis associated with a number of human muscle diseases. Our data suggest that reactive oxygen and nitrogen species (ROS/RNS) and mitochondria are key regulators of intracellular Ca2+ signaling in skeletal muscle. They have led us to the following hypotheses: 1). Under physiological conditions, the appearance of sparks is suppressed by reduced cytosolic environment, which maintains a low activity of RyR1, and by mitochondrial Ca2+ uptake. 2). Increased cytosolic Ca2+ levels promote ROS/RNS production through mitochondrial Ca2+ overload and/or stimulation of ROS/RNS production by other cellular sources. 3). ROS/RNS stimulate spark production by enhancing the Ca2+ release activity of RyR1 and/or by inhibiting mitochondrial Ca2+ uptake. 4). Cytosolic Ca2+ levels are elevated in MH due to SR Ca2+ leak, and in DMD due to increased Ca2+ influx. In both disorders, the outcome of increased cytosolic Ca2+ is: a) enhanced ROS/RNS production b) oxidative modification of RyR1, c) enhanced Ca2+ sensitivity of the modified RyR1 and d) the appearance of Ca2+ sparks. To test these hypotheses, we will carry out the following Specific Aims using electrophysiological methods and state-of-the-art imaging techniques (single and two-photon confocal imaging, digital photometry, UV-laser flash photolysis of caged compounds). We propose to: 1). Determine the mechanisms connecting cytosolic Ca2+ signals, mitochondrial Ca2+ uptake and ROS/RNS generation in muscle under physiological conditions. 2). Define how altered ROS/RNS generation affect cellular Ca2+ homeostasis in muscle from MH-susceptible and mdx mice (a mice model of DMD).

Public health relevance
PUBLIC HEALTH RELEVANCE: Release of Ca2+ from intracellular Ca2+ stores is a key step of excitation-contraction coupling. Alterations in skeletal muscle excitation-contraction coupling are associated with human diseases such as Hypokalemic Periodic Paralysis, Malignant Hyperthermia and Central Core Disease and, hence, defining the molecular mechanisms regulating the primary event in ECC is crucial for developing new therapeutic interventions in these diseases. The proposed experiments will provide us with new information about the mitochondrial control of Ca2+ signaling in skeletal muscle, and bring us one step closer to the understanding of a whole range of hereditary and acquired muscle disorders associated with metabolic and mitochondrial dysfunctions and Ca2+ mishandling. Narrative Release of Ca2+ from intracellular Ca2+ stores is a key step of excitation-contraction coupling. Alterations in skeletal muscle excitation-contraction coupling are associated with human diseases such as Hypokalemic Periodic Paralysis, Malignant Hyperthermia and Central Core Disease and, hence, defining the molecular mechanisms regulating the primary event in ECC is crucial for developing new therapeutic interventions in these diseases. The proposed experiments will provide us with new information about the mitochondrial control of Ca2+ signaling in skeletal muscle, and bring us one step closer to the understanding of a whole range of hereditary and acquired muscle disorders associated with metabolic and mitochondrial dysfunctions and Ca2+ mishandling. __SpecificAimsTextDelimiter__ a). SPECIFIC AIMS Ca2+ controls numerous cellular processes in skeletal muscle and alterations in Ca2+ homeostasis are associated with human diseases such as Duchenne Muscular Dystrophy (DMD), Malignant Hyperthermia (MH) and Central Core Disease (CCD). Defining the molecular mechanisms regulating intracellular Ca2+ signaling is a crucial step for developing new therapeutic interventions in these and other myopathies. The release of Ca2+ from the sarcoplasmic reticulum (SR) via Ca2+ release channels (ryanodine receptors, RyRs) is a key step in skeletal muscle excitation-contraction coupling (ECC). It is triggered through a direct interaction of the plasmalemmal voltage sensors (dihydropyridine receptors, DHPRs) with RyRs. This initial voltage-induced Ca2+ release (VICR) is thought to be amplified by Ca2+-induced Ca2+ release (CICR), manifest as Ca2+ sparks. Initially discovered in heart, Ca2+ sparks appear to result from CICR via a group of coupled RyRs. In mammalian skeletal muscle, however, Ca2+ sparks are not seen under normal conditions (either at rest or during physiological stimuli) [1, 2]. Ca2+ release from the SR appears to be controlled exclusively by voltage sensors. Nevertheless, mammalian muscle develops spontaneous spark-like activity in a variety of pathological states (e.g. impaired metabolism, stress such as osmotic shock or strenuous exercise, or disease [3-6]). The molecular underpinnings of Ca2+ sparks in mammalian muscle are unknown, but elucidation of these mechanisms is a prerequisite to preventing changes in Ca2+ homeostasis in muscle disease. Our recently published data suggest that reactive oxygen and nitrogen species (ROS/RNS) and mitochondria are key regulators of intracellular Ca2+ signaling in skeletal muscle. Using permeabilized skeletal muscle fibers, we have established that spark generation is promoted by: a) degradation of mitochondrial redox potential, b) inhibition of mitochondrial Ca2+ uptake, c) reduction of the ability of mitochondria to scavenge ROS [3, 4]. With the intact fiber preparation, we have found that: a) osmotic shock enhances ROS production by NAD(P)H oxidase (NOX) and mitochondria, b) Ca2+ sparks evoked by osmotic shock are inhibited by ROS scavengers [7]. In addition, with cells isolated from mdx mice and mice with MH mutation in RyR1 we have shown that: a) ROS/RNS levels are elevated in these mice, b) these elevations are at least partially due to enhanced ROS production by mitochondria, c) in vivo treatment with antioxidants attenuate the pathophysiological responses and delay the development of myopathy in MH mice (Preliminary Data and [8]). In addition, data from other laboratories indicate that in vivo treatment with antioxidants also partially restored force production and ameliorated muscle pathophysiology in mdx mice [9, 10]. These findings indicate an important link between mitochondrial Ca2+ handling, cellular ROS/RNS production and spontaneous Ca2+ spark activity in skeletal muscle. Based on them we had developed the following set of testable working hypotheses: 1. Under physiological conditions, the appearance of spontaneous sparks is suppressed by reduced cytosolic environment, which maintains a low activity of RyR1, and/or by mitochondrial Ca2+ uptake. 2. Increased cytosolic Ca2+ levels promote ROS production through mitochondrial Ca2+ overload and/or stimulation of ROS/RNS production by other sources (e.g. NOX). 3. ROS stimulate spark production by enhancing the Ca2+ release activity of RyR1 and/or by limiting mitochondrial Ca2+ uptake. 4. Cytosolic Ca2+ levels are elevated in MH due to SR Ca2+ leak, and in the mdx mice due to increased Ca2+ influx. In both disorders, the outcome of increased cytosolic Ca2+ is: a) enhanced ROS/RNS production b) oxidative/nitrosative modification of RyR1, c) enhanced Ca2+ sensitivity of the modified RyR1 and d) the appearance of Ca2+ sparks. These hypotheses will be tested in the following Specific Aims that employ electrophysiology and state-of-the- art imaging techniques (single and two-photon confocal imaging, digital photometry, UV-laser flash photolysis of caged compounds). 1. Determine the mechanisms connecting cytosolic Ca2+ signals, mitochondrial Ca2+ uptake and ROS generation in muscle under physiological conditions. We will a) establish the efficiency of skeletal muscle mitochondria to take up Ca2+ released from the SR during physiological ECC, b) test if mitochondrial Ca2+ uptake stimulates ROS production, c) define the role of ROS in generation of Ca2+ sparks and d) determine if ROS ultimately compromise mitochondrial Ca2+ uptake. For this, cytosolic and mitochondrial Ca2+ transients, as well as ROS production will be studied in intact cells during electrical stimulation, following photolytic release of Ca2+ from DM-nitrophen or photoactivated introduction of exogenous ROS inside the cell. 2. Define how altered ROS generation affects cellular Ca2+ homeostasis, and Ca2+ sparks, in muscle from MH-susceptible and mdx mice. MH and mdx mice exhibit evidence of profound oxidative stress. We will a) determine if the muscle of these mice exhibits augmented Ca2+ signals (including sparks) at rest, upon electrical stimulation, and upon pathological stimuli (e.g. mechanical stretch or heat for mdx and MH, respectively), b) examine the ability of antioxidants and scavengers (applied in situ as well as in vivo) to prevent these changes, c) directly assess the oxidative/nitrosative changes in RyR1 in both animal models and examine if the changes result in the altered Ca2+ sensitivity of SR Ca2+ release.